Detection of Colorectal Cancer Susceptibility Loci Using Genome-Wide Sequencing

DESCRIPTION (provided by applicant): Colorectal cancer (CRC) is the second leading cause of cancer death in the US. Linkage studies and genome-wide association studies (GWAS) have successfully identified high-penetrance mutations such as those that occur in APC or DNA mismatch-repair genes, as well as low-penetrance variants such as 8q24 and SMAD7. However, these variants explain only a fraction of the heritability of CRC. This is not surprising, as contributions from large classes of genetic variation, specifically less frequent and rare singl nucleotide variants (SNV) with allele frequency of 0.1-5%, insertion/deletions (indels), and copy number variants (CNVs), have not been systematically investigated across the genome. These genetic variants are predicted to have stronger effect sizes than common low-penetrance variants and are postulated to explain a substantial proportion of the heritability of CRC. To comprehensively identify these variants across the genome, we propose to use next generation technology to sequence the whole genome with 12x coverage in 2,123 high-risk CRC cases and 2,123 controls (Aim 1.1). These cases and controls will be selected from our existing Genetics and Epidemiology of Colorectal Cancer Consortium (GECCO; U01CA137088, PI: Peters) of 15 well-characterized prospective cohorts and case-control studies. We demonstrate that combining whole genome sequence data with imputation using existing GWAS data in large sets of case-control studies allows a powerful and efficient screen for CRC susceptibility loci. This method is particularly well suited to identifying less frequent and rare SNVs, indels, and CNVs. Accordingly, in Aim 1.2 we use the sequencing data from Aim 1.1 to impute ~20M variants in an additional 8,958 CRC cases and 10,212 controls with existing GWAS data. We will test the associations between CRC risk and variants (sequenced and imputed) in a total of 11,081 cases and 12,335 controls. In Aim 1.3, we will replicate the most promising loci by genotyping 3,000 variants in 8,827 independent CRC cases and 8,595 controls. In Aim 2, we will investigate gene-environment interactions for directly sequenced and imputed variants, utilizing GECCO studies, which have detailed clinical and epidemiologic data that have already been harmonized across studies. To improve the power for Aim 1 and 2, we will apply novel statistical methods. This project brings together a highly qualified, multidisciplinary team of investigators with expertise in CRC research, biostatistics, population and statistical genetics, epidemiology, and next generation sequencing. We expect to identify several novel CRC susceptibility variants with effect sizes larger than previous GWAS findings. These results will improve our understanding of which genes are impacting CRC. Such knowledge about the underlying biology could have long term impacts on screening, treatment and disease prevention.

Public health relevance
PUBLIC HEALTH RELEVANCE: This multidisciplinary effort will investigate whether different types of genetic variations, including rare variants and structural variation, influence colorectal cancer risk in humans. Specifically, we will examine genetic variants across the entire genomes of colorectal cancer cases and controls to identify new genetic risk factors for colorectal cancer. Findings from this study will improve our knowledge of the full spectrum of genes that affect the risk of this severe disease. __SpecificAimsTextDelimiter__ 2. STATEMENT OF HYPOTHESIS AND SPECIFIC AIMS Colorectal cancer (CRC) is the second leading cause of cancer death in the US. It is estimated that up to 35% of CRC is explained by genetic factors. High-penetrance mutations, such as in APC or DNA mismatch- repair genes have been identified by linkage studies. In addition there have been notable successes identifying common single nucleotide polymorphisms (SNPs; allele frequency >5%) using genome-wide association studies (GWAS). However, these high- and low-penetrance variants, combined, explain only a fraction of CRC heritability. The contributions from large classes of genetic variation, specifically single nucleotide variants (SNV) with allele frequency of 0.1-5%, insertion/deletions (indels), and copy number variants (CNVs), have not been systematically investigated across the genome. These classes account for the vast majority of genetic variation and are predicted to have stronger effect sizes than common low-penetrance variants. Accordingly, it is expected that collectively they will explain a substantial proportion of the heritability of CRC. Next generation technology allows sequencing of the whole genome and comprehensive identification of several classes of genetic variants, specifically SNV, indels, and CNVs, across a wide range of allele frequency, including common (allele frequency >5%), less frequent (1-5%) and rare (<1%) variants. We demonstrate that combining whole-genome sequencing with imputation, using available GWAS data in a large set of case-control studies, will allow a powerful and efficient screen for CRC susceptibility loci, whose contributions have been missed to date. We will investigate samples from the Genetics and Epidemiology of Colorectal Cancer Consortium (GECCO; U01CA137088, PI: Peters), which includes 19,908 cases and 20,930 controls from well characterized case-control studies and cohorts. Most samples have existing GWAS data and detailed information on environmental risk factors that has been harmonized across studies. Building on the large GECCO resource, we aim propose the following specific aims: Aim 1. To identify novel SNVs, indels, and CNVs with an allele frequency as low as 0.1% that increase CRC susceptibility. 1.1. To comprehensively identify genetic variants (~20M) across the whole genome by sequencing 2,123 high-risk CRC cases and 2,123 matched controls. Using next-generation technology to sequence the entire accessible genome (85-90%) with 12x coverage, we propose to identify SNPs, indels, and CNVs with an allele frequency as low as ~0.1%. High-risk cases are defined as those with one or more first-degree family members with CRC and/or earlier onset disease (age at diagnosis <50 years) and without known family syndromes. 1.2. Using sequencing data from Aim 1 .1, we will impute the ~20M identified variants in an additional 8,958 CRC cases and 10,212 controls with GWAS data and subsequently test the associations between CRC risk and variants (sequenced and imputed) in a total of 11,081 cases and 12,335 controls. In order to identify novel susceptibility alleles and select the most promising loci for replication in Aim 1.3, we will use: a) logistic regression to test individual-variants with allele frequencies >1%; and b) genetic-burden tests, which aggregate contributions of rare variants (<1%). 1.3. To replicate findings from Aim 1.1 and 1.2 in an additional 8,827 CRC cases and 8,595 controls. The most significant variants indentified in Aim 1.2 will be genotyped and tested in independent cases and controls (total 3,000 variants, including ancestry-informative markers). Aim 2. To investigate whether known environmental risk factors for CRC modify genetic susceptibility to CRC. Utilizing GECCO's rich resource of harmonized environmental data, we will investigate whether the contributions of genetic risk factors are modified by known CRC risk factors, such as smoking, diet, medication use, and obesity. This project brings together a highly qualified, multidisciplinary team of investigators with expertise in colorectal cancer, biostatistics, population and statistical genetics, epidemiology, and next-generation sequencing. Because key investigators on this proposal are already leaders in next-generation sequencing projects, including the 1000GP and the Exome Sequencing Project, we have ample relevant experience to successfully conduct the study. We expect that we will identify several novel CRC susceptibility variants with larger effect sizes than previous GWAS findings. These results will improve our understanding of which genetic regions impact CRC risk and, hence, enhance our knowledge of the underlying biology of CRC and the functional impact of genetic variants. Knowing the genes involved in CRC development could stimulate the development of new therapies and preventive approaches through the discovery of new etiologic pathways and drug targets.